Systemic RNA Delivery to Tumors

ABSTRACT
The use of RNA technologies to specifically target genetic alterations in tumor cells has shown great potential of
becoming a novel therapy modality for cancer treatment. Nevertheless, systemic delivery of RNA agents such
as messenger RNA (mRNA) to tumor cells in vivo commonly faces multiple barriers, including low stability, rapid
elimination by renal excretion, insufficient cellular uptake, poor endosomal escape, and transient activities. Our
long-term objective is to develop robust nanoparticle (NP) platforms for effective and safe RNA delivery to solid
tumors, and along with cancer target validation in vivo, to eventually transition the RNA nanomedicines into
clinical development. In the last funding cycle, a lipid-polymer hybrid RNA NP system has been engineered with
favorable features, such as small size, high RNA encapsulation, efficient cytosolic translocation, and relatively
long blood circulation. We have also pioneered the application of these hybrid NPs for mRNA delivery to restore
tumor suppressors (e.g., PTEN) in different cancer types including prostate cancer (PCa) and non-small cell lung
cancer, which represents a novel approach to cancer treatment that is independent of oncogene antagonism. In
our latest work, we further reveal that PTEN restoration in PTEN-null/mutated murine tumor cell lines can induce
immunogenic cell death (ICD). Preliminary in vivo studies show that PTEN mRNA NP treatment triggers cytotoxic
T cell responses, modulates the immunosuppressive tumor microenvironment, and improves the responses of
immune checkpoint blockade therapy. In this renewal application, we propose to i) address the unique challenge
of transient bioactivity in mRNA delivery by developing a new generation of hybrid mRNA NPs, and ii) apply the
new hybrid mRNA NPs to explore PTEN restoration-induced ICD and evaluate the anti-tumor efficacy of PTEN
restoration along with immune checkpoint blockade. Specifically, the three Aims underlying the proposal are: 1)
To optimize the new generation of hybrid NPs and study the NP-mediated long duration of mRNA bioactivity with
the goal of achieving prolonged PTEN expression in PCa tumors using as infrequent injections as possible; 2)
To apply the optimized mRNA NPs to investigate the mechanisms underlying PTEN-mediated ICD and anti-
tumor immune responses and to evaluate the therapeutic effect and safety in subcutaneously grafted, orthotopic,
and transgenic models of PCa; and 3) To expand the new hybrid mRNA NPs to systemic co-delivery of PTEN
mRNA and CpG oligodeoxynucleotide (a toll-like receptor-9 agonist) for stronger ICD and to test the co-delivery
NPs for PCa treatment together with immune checkpoint inhibitors. We expect that successful completion of this
project will lead to development of a novel synthetic mRNA nanotherapy that could benefit cancer patients with
loss/mutation of PTEN. Moreover, this NP delivery strategy could be readily expanded to other tumor suppressor-
encoding mRNAs for various malignancies.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PCa) remains a serious social and economic burden, and the American Cancer Society (ACS) estimates 191,930 new cases and 33,330 deaths in the United States from this disease in 2020. This project aims to develop a novel mRNA delivery platform for effectively restoring tumor suppressor PTEN and inducing anti-tumor immune responses in PCa, which can also be combined with immune checkpoint blockade therapy for highly potent cancer treatment. We expect this research project will form the foundation for development of a new, rational combination therapy that could significantly extend the lives of PCa patients.